Exploring the shared genetic architecture of white blood cell variation and childhood acute lymphoblastic leukemia

PROJECT SUMMARY/ABSTRACT Acute lymphoblastic leukemia (ALL) is a cancer of white blood cells, and the most common malignancy in children under 15 years of age. Despite significant advances in treatment, children who survive ALL face severe long-term therapy-related morbidities. Moreover, ALL is still one of the leading causes of cancer-related mortality in children. Prevention of childhood ALL, therefore, remains an essential goal, and is dependent on understanding the etiology of this disease, which forms the focus of this study. Genome-wide association studies (GWAS) have identified genetic risk factors for childhood ALL at several genes, many of which control white blood cell (WBC) development, including IKZF1, ARID5B, and CEBPE. The majority of variants associated with ALL risk are also associated with variation in WBC traits, suggesting a shared genetic basis between normal blood cell development and blood cancer. Thus, a comprehensive study of the role of heritable WBC trait variation in risk of childhood ALL is warranted. To this end, the first aim of this study is to catalog common genetic variants associated with variation in WBC traits, namely counts of lymphocytes, monocytes, neutrophils, eosinophils, basophils, and total WBCs, via GWAS using genetic and blood cell phenotype data from ~330,000 individuals of European ancestry, free of cancer and immune-related disease, from the UK Biobank study. The second aim will be to assess the contribution of WBC trait-associated variants to risk of childhood ALL by: (1) testing association of these variants with childhood ALL using GWAS results from a European- ancestry case-control study from the California Cancer Records Linkage Project, including 1184 ALL cases and 3551 controls, with replication of novel risk loci in an independent GWAS of 959 ALL cases from the Children's Oncology Group and 2624 controls from the Wellcome Trust Case Control Consortium; and (2) using the WBC trait-associated variants as genetic instruments in Mendelian randomization analyses to test the causal relevance of each WBC trait in risk of childhood ALL. Our final aim is to identify putative causal genes associated with childhood ALL, and to assess the shared biological pathways underlying WBC trait variation, through transcriptome-wide association studies (TWAS) using genetic prediction models of whole blood gene expression. We will perform TWAS in: (1) the ALL case-control study, to discover genes the expression of which is associated with ALL risk; and (2) the UK Biobank data to identify genes whose expression is also associated with each WBC trait. This will be the first examination of the causal relationship between WBC indices and ALL risk. Our results will shed light on the biology of ALL, provide insight into the extent to which ALL risk genes operate via WBC-associated mechanisms, and may highlight potential avenues for risk-stratification and prevention.

Public health relevance
PROJECT NARRATIVE The causes of acute lymphoblastic leukemia (ALL), the most common childhood cancer, are not fully understood. The goal of this project is to investigate the role of heritable variation in white blood cell traits in risk of childhood ALL, to identify novel genetic risk factors and genes that may confer leukemia risk via effects on white blood cell variation. This novel approach to childhood ALL epidemiology will gain insight into the biology of ALL development, and may highlight avenues for disease prevention, risk-stratification, and targeted therapies.